Creating AI/ML-ready data for single cell proteomics

Project Summary: Supplement to 1R01GM147653-01
Brief parent R01 summary
Life is the result of dynamic interactions that occur within and among individual cells. Single cell
analyses characterize a sample’s diversity and each individual cell’s state and ability to respond
to the environment. Single cell proteomics (SCP) is rapidly emerging and can quantify > 1000
proteins per cell, a level of coverage sufficient to categorize cell types and reveal characteristic
cellular functions. Significant advances in instrumentation and sample preparation are making
SCP more broadly accessible. Yet advances in data acquisition have not been paired with
advances to computational tools.
The parent award creates algorithms specifically optimized for the unique nature of SCP data,
and will radically improve accuracy and coverage of the single cell proteome. The aims of the
parent award address algorithmic challenges in spectrum identification (Aim 1) and protein
quantification (Aim 2). The project also creates some single cell proteomics data for
benchmarking purposes (Aim 3).
Goals of the Supplement
The Supplement proposal is a collaboration between the MPIs of the parent award and experts
in machine learning. The goal of the supplement is to improve the AI/ML readiness of single cell
proteomics data through two primary tasks. First, we will define and implement file formats that
are more amenable to machine learning than the formats for proteomics data and results, as
current formats are bloated and insufficient and cannot scale to the necessary level of data
required for machine learning. Second, we will improve software tools for the capture of
meta-data, which is essential for describing the experimental design. With the successful
completion of these two tasks, we will demonstrate that data from single cell proteomics
experiments are immediately usable for a variety of machine learning tasks available at
proteomicsML.org.